Dysfunctional Renin-Angiotensin System in Septic Shock

Scientific Abstract:
Sepsis and septic shock are global healthcare problems associated with mortality rates of up to 40% despite
best therapy efforts. Circulating markers of septic shock severity may constitute a clinically relevant approach
to individualize therapy and resuscitation for those patients at risk for poor outcomes early in the course of
the disease, which may facilitate early and more precise intervention to improve patient outcomes. However,
currently used septic shock biomarkers including lactate, may be non-specific, and have variable impacts on
prognosis and/or disease management. Activation of the renin-angiotensin-aldosterone system (RAAS) is an
early event in septic shock and recent data has shown that elevated renin, is more predictive of worse
outcomes in septic shock than lactate, as well as a more relevant biomarker for mortality. However, our
preliminary data suggest that activation of the RAAS downstream from renin, particularly the Angiotensin
Converting Enzyme (ACE)- Angiotensin II (Ang II)-AT1 receptor axis is blunted, thus contributing to the
severity of septic shock through a reduced ability to maintain adequate blood pressure and tissue perfusion,
as well as an attenuated immune response. The current project proposes a randomized clinical trial to
precisely determine the benefit of exogenous Ang II versus norepinephrine (conventional care)
treatment in septic shock patients. Moreover, we will determine whether there are more precise and
complete measures of renin and other RAAS components (prorenin, aldosterone, Angiotensinogen
(Aogen), DPP3, ACE, ACE2 and Ang II) that provide stronger associations and better predictors of
septic shock severity. This approach may inform more appropriate treatment regimens and improve
outcomes for these patients. Specifically, Aim 1 proposes a clinical trial to compare the benefits of Ang II
treatment and the norepinephrine (NE). Aim 2 will assess protein levels of renin, prorenin, aldosterone, Ang
II, Aogen (total and intact), DPP3 and ACE, as well as their ratios in comparison to serum lactate as the
strongest predictor of disease severity and outcomes in septic shock patients prior to and following Ang II and
NE treatment. Aim 2 also establishes the regulation of Aogen by serum factors from septic shock patients
prior to and following Ang II and NE treatment. Aim 3 will assess the response of the immune system
regarding monocyte function and cell signaling events associated with the RAAS in the septic shock before
and after treatment. Successful accomplishment of our aims will provide the capability to improve endotyping
of septic patients by establishing the most precise and robust measurement of renin (and RAAS dysfunction).
This work will improve staging and clinical precision and will facilitate the criteria for therapeutic development
of targets in septic shock.

Public health relevance
Clinical Relevance: Sepsis and septic shock are global healthcare problems associated with high mortality rates and few treatment options. Our project proposes more precise and complete measures of renin and other renin-angiotensin- aldosterone system components that may provide stronger associations and better predictors of septic shock severity in a clinical trial comparing Angiotensin II and norepinephrine treatments. This approach may inform more appropriate treatment regimens and improve outcomes for septic shock patients and facilitate the criteria for therapeutic development of targets in septic shock.